Bile acids restrict functional reprogramming of myeloid-derived suppressor cells in tumor beds

ABSTRACT
The expansion of myeloid-derived suppressor cells (MDSC) in tumor-bearing hosts has emerged as a primary
mechanism to limit protective anti-tumor T cell responses and a major obstacle to the success of cancer
immunotherapy. It is therefore imperative to develop new effective therapeutic strategies to overcome the
immune restricting effects induced by MDSC in tumors. Our recent studies demonstrated that MDSC chronically
activate an integrated signaling network known as the unfolded protein responses (UPR) as a reaction to the
sustained and pronounced endoplasmic reticulum (ER) stress induced by the precarious conditions of the tumor
microenvironment (TME). Also, conditional deletion of the UPR-related PKR-like ER kinase (PERK) functionally
reprogrammed MDSC into immunostimulatory cells that partially restore protective anti-tumor immunity in tumor
beds. Importantly, our new Preliminary Results demonstrate a compensatory accumulation of highly immune-
regulatory primary and secondary bile acids (BAs) in PERK-ablated MDSC in tumors. BAs are synthetized in the
liver and intestine as final products of cholesterol metabolism and signal through priming of farnesoid X receptor
(FXR) transcription factor, which was found increased in PERK-null MDSC and augmented MDSC suppressive
activity. Based on these crucial findings, we hypothesize that the accumulation of intracellular BAs restricts the
transformation of PERK-null MDSC in tumors into myeloid cells that promote sustained protective T cell immunity
through activation of FXR and a subsequent induction of the compensatory UPR mediators, IRE1→Xbp1. We
also propose that inhibition of PERK plus IRE1 will completely overcome MDSC-linked suppression in tumors
and synergize with T cell and checkpoint immunotherapies. We propose the following Specific Aims:
In Aim 1, we will determine the restrictive action of the accumulated BAs in the functional transformation of
PERK-null MDSC into myeloid cells that prime sustained protective anti-tumor T cell immunity.
In Aim 2, we will elucidate the mechanisms whereby BAs restrict PERKKO MDSC transformation in tumors.
In Aim 3, we will test the prediction that combined inhibition of PERK and IRE1 completely overcomes MDSC-
associated immunosuppression and enhances the effectiveness of cancer immunotherapy.
The metabolic mediators driving the immunosuppressive functionality of MDSC in tumor beds remain poorly
described. Thus, development of the Aims will have a profound impact on the field by substantiating a major
metabolic signal whereby tumors restrict the functional transformation of MDSC after targeting the ER stress
mediator, PERK. Also, our proposal will provide a mechanistic rationale for the development of novel therapeutic
approaches to entirely reprogram immunosuppressive myelopoiesis in tumor-bearing hosts, which is likely to
synergize with cancer immunotherapy and provide new biomarkers for tumor-MDSC reprogramming.

Public health relevance
PROJECT NARRATIVE This application will identify an elusive metabolic mechanism centrally governing the function of myeloid-derived suppressor cells (MDSC) in tumors, which could significantly increase the efficacy of promising approaches for cancer immunotherapy. Specifically, information gathered from this effort is expected to: 1) provide insights into the metabolic signals underlying the tolerogenic polarization and reprogramming of MDSC in tumors; 2) set the foundation for the development of novel strategies to functionally reprogram immunosuppressive myelopoiesis in cancer; and 3) enhance the effectiveness of major anti-cancer treatments by transforming “cold” tumors into “hot” malignancies highly infiltrated by reactive T cells and reprogrammed immunogenic myeloid cells that promote sustained anti-tumor activities.